Web-Enabled Cognitive/Neuropsychological Evaluation System

The objective of the Phase II project is to prove that Creare's innovative Web-Enabled Cognitive/Neuropsychological Evaluation System for Substance Abusers improves clinical outcomes and provides the enabling infrastructure to collect data from large cohorts of subjects involved in human subject tests that required or would benefit from frequent evaluation and monitoring.